Enhancing cognitive function in breast cancer survivors through community-based aerobic exercise training

Project Summary
Women aged 50+ years comprise 77% of breast cancer diagnoses and 93% of all breast cancer survivors (BCS).
Unfortunately, the interaction between cancer treatment and normal aging often results in a number of health
sequelae. Up to 75% of BCS suffer cognitive changes during treatment, and over 45% experience clinically
significant cognitive decline pre- to post-treatment. An optimum treatment for cancer-related cognitive
impairment (CRCI) is likely one integrating interventions known to improve cognition in similar populations, such
as older adults. Our previous research supports the efficacy of moderate-intensity aerobic exercise training for
improving cognitive function in older adults without cancer. This work suggests that cardiorespiratory fitness (i.e.,
peak VO2) and brain structural and functional integrity (e.g., white matter microstructure, resting state functional
connectivity) may underlie exercise-induced changes in cognitive function. We recently applied an aging
framework to gain preliminary information on the effects of physical activity on cognitive function in BCS. Our
work in this area suggests that aerobic exercise training may similarly ameliorate cognitive decline due to cancer
and that cancer-related fatigue may also represent a mechanism of exercise’s cognitive benefits in the context
of cancer. Our preliminary data in aging and cancer, along with the well-documented benefits of exercise relative
to proposed CRCI mechanisms (e.g., cardiorespiratory fitness, fatigue), provide a compelling argument in
support of aerobic exercise training for improving cognitive function in BCS. While evidence toward efficacy in
this area is growing, few large trials have been conducted and none, to our knowledge, with consideration of
dissemination and implementation a priori. We propose a clinical trial in which post-menopausal BCS (3-24
months post primary adjuvant therapy) will be randomized to a community-based aerobic exercise program or
attentional control. This study utilizes a Hybrid Type I effectiveness-implementation design to investigate clinical
effectiveness while gathering information on implementation success associated with our novel, community-
based approach. Our exercise protocol is based upon our previous studies with demonstrated efficacy in older
adults, and our community-based approach is based upon our previous studies with demonstrated
implementation success in BCS and post-menopausal women without cancer. The specific aims are: 1) Examine
the effectiveness of a 6-month, community-based aerobic exercise program, compared to control, on indicators
of cognitive function (i.e., cognitive performance, neuroimaging metrics of brain health, self-reported cognitive
impairment) in post-menopausal BCS; and 2) Gather information on the intervention’s potential for scalability as
defined by the RE-AIM framework (i.e., reach, effectiveness, adoption, implementation, maintenance). We will
also explore intervention interactions with clinical variables (e.g., moderators: chemotherapy treatment regimen,
obesity status) and potential pathways by which aerobic exercise, compared to control, influences cognitive
function (i.e., mediators: neuroimaging outcomes, cardiorespiratory fitness, fatigue).

Public health relevance
Narrative: Up to 75% of breast cancer survivors suffer cognitive changes during treatment, and over 45% experience clinically significant cognitive decline pre- to post-treatment. Consistent evidence in older adults and growing evidence in breast cancer survivors suggests aerobic exercise training may reduce cancer-related cognitive decline. This study will compare changes in cognitive function and brain health in post-menopausal breast cancer survivors randomized to either: 1) a community-based aerobic exercise program; or 2) attentional control (health education).